Vaccine induction of Salmonella-specific Th1 memory cells

PROJECT SUMMARY
A successful vaccine for systemic Salmonella infections will need to induce Th1 memory cells, but the tissue
location and required functionality of these cells is poorly understood. Our preliminary data show that liver
Tissue Resident Memory (TRM) CD4 T cells express higher levels of IL-18R and are more protective than the
corresponding TRMs cells in the lamina propria. In this application, we will test, (i) whether IL-18R expression
allows non-cognate responsiveness and robust TRM-mediated protection, and (ii) whether the use of a mRNA
nanoparticle delivery system can induce this protective population in the liver of vaccinated mice.

Public health relevance
PROJECT NARRATIVE Although progress has been made in the development of ViCPS-conjugate vaccines for typhoid, the majority of fatal systemic Salmonellosis is caused by bacterial that lack expression of ViCPS. CD4 Th1 memory T cells are required to resolve this non-typhoid systemic disease, meaning that new vaccine approaches will be required. This application explores a new mRNA vaccine approach for Salmonella that attempts to elicit hepatic Tissue-Resident Memory Th1 cells. Our preliminary data show that these cells are essential for protection and differ from other TRMs in expression of IL-18R. Our goal is to test the requirement for IL-18R in protective immunity and elicit TRMs using an mRNA vaccine approach. Successful completion of this exploratory project will validate a new approach to vaccination for intra-macrophage pathogens.